El Trabajo no te Debe Danar: Reduction of Hazardous Exposures in Small Businesses through a Community Health Worker Intervention

PROJECT SUMMARY
This project aims to reduce negative health outcomes in small businesses that primarily employ high-risk
Latino workers by characterizing their exposures to hazardous chemicals and assessing if a community health
worker (CHW) intervention is effective at decreasing these exposures. Although preventable by definition,
occupational disease and injuries are leading causes of death in the United States, with a disproportionate
burden faced by Latinos. Small businesses pose a particular risk. They are more likely to employ low-wage
Latino workers, and often use hazardous solvents including volatile organic chemicals that can cause asthma,
cancer, cardiovascular, and neurological disease; yet their workers lack access to culturally and linguistically
appropriate occupational health and pollution prevention information due to economic, physical, and social
barriers. CHW-led interventions and outreach in Latino communities have documented increased access to
health care and health education and reduced workplace exposures among farmworkers. CHWs are an
innovative method to bridge the gap between these small business communities and other stakeholders. The
proposed project will capitalize on established partnerships between the University of Arizona, the Sonora
Environmental Research Institute, Inc. and the El Rio Community Health Center. A community-engaged
research framework will be used to complete the following specific aims: 1) quantify and identify exposures to
hazardous chemicals in the two high risk small business sectors common in our target area (i.e., auto repair
shops and beauty salons); 2) work collaboratively with business owners, trade groups, workers and CHWs to
design an industrial hygiene – enhanced CHW intervention tailored for each small business sector; and 3)
conduct a cluster randomized trial to evaluate the effectiveness of the CHW intervention at reducing workplace
exposures to volatile organic compounds and assess which factors led to successful utilization of exposure
control strategies in both male and female-dominated businesses. Businesses will be randomized to either an
intervention or delayed intervention group, both of which will receive incentives to participate including worksite
health screenings. CHWs will work closely with business owners and employees to select and implement
exposure-strategies appropriate for their worksite using a menu of complementary strategies of varying
complexity and cost. This innovative project has the potential to directly reduce occupational health disparities
through a CHW intervention that moves beyond providing occupational health education. The intervention will
overcome current barriers by helping marginalized Latino workers and small business owners who may have
limited education, literacy, and computer skills to understand the hazards associated with their work, and will
empower them to have greater control over their occupational exposures, with the ultimate goal of preventing
occupational disease and reducing health disparities.

Public health relevance
PROJECT NARRATIVE Occupational exposures contribute to minority health disparities. This study will formally evaluate if a community health worker intervention can effectively reduce workplace exposures in marginalized small businesses to hazardous chemicals. Through face-to-face encounters, this study will increase the capacity of workers with limited education, literacy, and computer skills to understand workplace hazards and effective control options to reduce exposures and prevent occupational disease.